TRAINing in Aging Health & Health Services for Alzheimer's Disease and Related Dementias (TRAIN-ADRD)

Project Summary
Currently, more than 6 million Americans are living with Alzheimer's disease and related dementias (ADRD); a
number that is expected to more than double by 2050. The projected growth in population aging and dementia
requires an army of skilled researchers to accelerate research on ADRD and produce evidence that provides
better clinical care and services for people living with dementia and their families - goals of the National Plan to
Address Alzheimer's Disease. The proposed training program, "TRAINing in Aging Health & Health Services
for Dementia Care (TRAIN-AD),” seeks to develop the next generation of researchers skilled at integrating
epidemiological and biostatistics methods into health services research with applications in dementia care.
Over the last decade, major advances in the knowledge base of gerontology, with an emphasis on ADRD,
have been occurring thanks to a proliferation of genetic, clinical, epidemiological and health services data that
can be leveraged to address novel research questions. Researchers of the future must know how to maximize
the use of these data sources. Thus, in the future there will be a premium placed on young investigators
cognizant of methodological advances ranging from new strategies for collecting, merging and managing data
sets; new and refined statistics and analytic strategies; and major new tools for integrating social, health, and
biological data.
The proposed renewal of our training program addresses the major goals of the NIA Strategic Plan for
research, by educating well-trained researchers with multi-disciplinary experience and a broad understanding
of the biological, social, health, service and policy aspects of aging and dementia care. Building upon a rich
research and training environment with over two decades of experience training investigators focused on
understanding how the older adults use and are affected by health services, this competing renewal application
will: 1) Recruit high quality doctoral students into aging research with a specific focus on ADRD; 2) Provide
training in substantive topics relevant to health services research in aging and ADRD; 3) Provide education in
epidemiological and statistical methods with applications to aging and ADRD research; 4) Provide research
experiences in ongoing health services research projects related to aging and ADRD; and 5) Prepare students
for research careers as independent scientists and leaders. Since our last renewal, the number and quality of
applicants has tripled and over half of the students this training grant has supported are from historically under-
represented groups. Given the increase in NIA-funded ADRD-related research among our faculty and
students, we are requesting 4 predoctoral slots who will be served by 36 trainers under this renewal.

Public health relevance
PROJECT NARRATIVE Building upon a rich, interdisciplinary research environment with numerous NIA-funded investigators, this training grant seeks to support predoctoral trainees in the Brown University School of Public Health with a focus on aging health and health services for dementia care. The objective of this training program is to meet the growing demand for investigators conducting research on the biological, psychological and social forces that shape the manner in which older Americans, particularly older adults living with dementia, utilize health services and how those services affect their health and well-being.